ATP-dependent and independent mechanisms of regulating chromatin states

Abstract
Chromatin provides a means to compartmentalize the genome into active (euchromatin) and heritably repressed
(heterochromatin) states. Changes in these states accompany changes in cellular differentiation and are
essential for stabilizing cellular identity. Both types of chromatin states are maintained and rearranged by the
combined action of diverse ATP-dependent chromatin remodeling motors and specific chromatin binding
proteins. The proposed work is aimed at studying the core mechanisms of some of the major
chromatin regulators to achieve a better understanding of how their activities are regulated in vivo. Using a
variety of biophysical approaches, we have uncovered that ATP-dependent remodelers use sophisticated auto-
inhibition based mechanisms. We have also uncovered hexasomes as the preferred substrate for one type of
conserved remodeler. These findings provide a biophysical basis for further probing why different remodelers
have different biological roles. We had previously discovered phase-separation behavior by HP1 proteins, the
core components of heterochromatin. Since then, we have uncovered that phase-separated heterochromatin
reconstituted in a test-tube possesses several of the biophysical properties attributed to heterochromatin in cells.
Here we will build on these new discoveries to ask the following questions:
1. Why are their differences in mechanism between remodelers from different classes?
2. How does action of remodelers at the nucleosome scale impact chromatin at bigger scales?
3. What is the role of phase-separation in heterochromatin regulation?

Public health relevance
Narrative Misregulation of chromatin states either via misregulation of ATP-dependent chromatin remodeling enzymes or misregulation of heterochromatin is strongly associated with cancer and developmental defects. Yet how chromatin remodeling enzymes work or how heterochromatin is assembled and regulated is poorly understood. This proposal combines biophysical approaches with cellular tests to tackle these challenging questions, with the goal of identifying key steps that are targets for regulation and that can be controlled for therapeutic intervention in the future.